HSR&D Senior Research Career Scientist Award

This proposed Senior Research Career Scientist (SRS) award is to support the activities of Dr.
Matthew Maciejewski, a health economist, Research Career Scientist and an established
Department of Veterans Affairs (VA) Health Services Research and Development (HSR&D)
investigator, allowing him expand his scientific, mentoring and service contributions. Dr.
Maciejewski’s research focuses on improving care and outcomes for Veterans with obesity or
multiple chronic conditions. This research is important because Veterans with obesity or
multiple chronic conditions incur a disproportionate share of VA expenditures and population-
based care models that effectively improve their health and health care are not yet established.
To address these important populations, Dr. Maciejewski’s research particularly focuses on
conducting quasi-experimental comparative effectiveness research of policies and programs
designed to help Veterans with obesity or multiple chronic conditions. The goal of these
evaluations is to whether existing programs and policies work as intended and which Veterans
realize the greatest benefits from them.
During his 20-year VA career, Dr. Maciejewski obtained HSR&D funding as Principal
Investigator (PI) for 8 IIRs, 2 R01s and 1 R21 from AHRQ, an ongoing R01 from NIDA, 2 RWJ
HCFO grants and contract funding from CMS that is in its 6th year. He has also been a co-
investigator on three dozen other VA and non-VA grants. Dr. Maciejewski’s studies as PI
helped to develop evidence on the utilization and quality of care for patients who received all or
part of their care at community-based outpatient clinics and impacts of the 2002 VA medication
copayment increase. Mostly importantly, Dr. Maciejewski and his team established evidence on
the long-term outcomes of Veterans receiving bariatric surgery. With NIDA R01 funding, he is
now examining long-term mental health outcomes that have not been widely examined in VA or
non-VA surgical cohorts.
In addition to Dr. Maciejewski’s research activities, he has served on national and international
committees. Recent activities include service on VA HSR&D grant review panels and co-chair of
the 2016 HSR&D State of the Art Meeting on Weight Management. Currently, Dr. Maciejewski
serves as Chair of Partnered Evidence-Based Policy Resource Center’s (PEPReC) Technical
Advisory Committee and as co-lead of the Research Data Sustainability Team responsible for
facilitating continuity of administrative and clinical data available for reuse as the VA transitions
to the Cerner EHR. He is a Statistical Associate Editor for JAMA and serves on the editorial
board for HSR. Provision of a VA HSR&D SRS award will allow Dr. Maciejewski to enhance his
research, mentoring and service contributions to the VA HSR&D mission to continue to conduct
of rigorous non-randomized comparative effectiveness studies, increase his participation in local
and national VA committees and train the next generation of health services researchers.

Public health relevance
The purpose of this award is to support the research, training and service activities of Dr. Matthew Maciejewski, who is a health economist, Research Career Scientist, and experienced Department of Veterans Affairs investigator. Over his 20-year HSR&D career, Dr. Maciejewski has led numerous research studies that improve our understanding of how best help Veterans manage their obesity or cardiometabolic conditions. This research is important because Veterans with obesity or multiple chronic conditions incur a disproportionate share of VA expenditures and population- based care models that effectively improve their health and health care are not yet established. He has contributed to the methods literature, played a leadership role in VA service and mentored fellows who have gone on to make major contributions.